Regulation of innate immunity by self-adjuvated MRNA vaccines

ABSTRACT
Mycobacterium tuberculosis (MTB), the causative agent of pulmonary and non-pulmonary
tuberculosis (TB), kills nearly 1.2 million people every year, whereas ~ one-third of the global
population is latently infected with Mtb. Bacillus Calmette-Guérin (BCG) is widely used as a
vaccine against TB, and over one billion doses have been used so far although it only partially
protects children from TB but not adults. We discovered that a novel-self adjuvanted mRNA
(SamR) vaccine delivering MTB-derived antigen can protect mice against TB. In this proposal, we
propose to develop new generation mRNA-based vaccines route to protect against TB using a
multi-antigen-based platform which also integrates an adjuvant. A ‘systems immunology’
approach will be used to evaluate innate immunity mechanisms that control adaptive immune
responses in mice vaccinated using our improved mRNA vaccines. Our goals are:
Specific Aim-1: To develop a new generation mRNA-based vaccines expressing protective
antigenic epitopes of Mycobacterium tuberculosis (MTB) in combination with in-built adjuvant
peptides. We will develop multiple MTB protein antigen expressing mRNA vaccines that contain
a unique self-adjuvant to boost immune responses. We will synthesize and evaluate more efficient
linear mRNA and/or circular RNA vaccines for tuberculosis and formulate them in nanoparticles.
Specific Aim-2: To characterize the molecular mechanisms of new generation mRNA vaccines.
We found that our new generation SamR-vaccines induced a robust activation of innate immunity
pathways (RIG-I NOD2 and TLR) in macrophages and dendritic cells. We will investigate the
molecular mechanisms of protein antigen-induced Immunogenicity and C5- induced adjuvanticity
using APCs from wild type C57Bl/6 mice, and transgenic mice that lack innate nodal genes.
Specific Aim-3: To determine the efficacy of SamR-vaccines against tuberculosis in wild type
and immunodeficient mice. We found that our novel vaccine activated trained immunity genes in
macrophages. Because BCG-induced trained and adaptive immunity declines in human children
by age 5 predisposing them to TB, we will investigate the boosting effect of our trained immunity
inducing SamR-vaccines for protection in BCG vaccinated mice. We will use both C57BL/6 and
our optimized immune competent and immunodeficient humanized model to identify parameters
of protection relevant to humans.

Public health relevance
NARRATIVE Mycobacterium tuberculosis (MTB), the causative agent of pulmonary and non-pulmonary tuberculosis (TB), kills nearly 1.5 million people every year, whereas ~ one-third of the global population is latently infected with MTB. Bacillus Calmette-Guérin (BCG) is widely used as a vaccine against TB, although it protects only partially. We have developed a new generation self-adjuvanted mRNA-based vaccines which can either protect against TB on their own or boost immunity generated by primary BCG vaccine. These vaccines are expected to improve public health.